NRI: Toward Safe and Reliable Robotic Eye Examinations

This project proposes to enable a complete system for robotic optometric I ophthalmic examination of
freestanding patients, including automated cornea , lens, and retinal imaging as well as eyeglass
prescription measurement. Robot-aided medical exams have the potential to improve access to
preventative medical care, improve health outcomes, reduce costs of care, and reduce disease
transmission risk, but they pose safety concerns due to the extremely close proximity of humans and
machinery. Moreover, patient interactions are extremely varied , so automating data collection in the
"long tail" of anomalous situations requires robust and adaptive perception and decision-making.
To address these safety and reliability concerns , this three-year project will integrate basic research in
real-time human motion sensing and robot motion planning with applied research in ophthamology and
biomedical imaging. This research will be conducted along three aims. Aim 1 will build the robot-mounted sensing instrument by augmenting the proposers' existing work in robotically-aligned optical
coherence tomography imaging with additional modalities. Aim 2 will address safety by leveraging
recent technical advances in sensors, real-time human tracking , human motion prediction , and robot
motion planning to implement active safety systems that eliminate robot-initiated collisions and minimize
human-initiated ones. Aim 3 will address evaluation and refinement of safety and reliability using large-scale studies on head / eye phantoms and smaller-scale studies on human subjects.

Public health relevance
Robot-assisted medical examinations have the potential to improve health outcomes, reduce costs of care, and reduce infection risks for medical personnel and patients. This project advances the state-of-the-art in robot-assisted eye examinations to achieve safe, comprehensive, and reliable no-touch imaging of eye structures.